Societal, Ancestry, Molecular AND Biological Analyses Of Inequalities (SAMBAI)

SAMBAI: Societal, Ancestry, Molecular and Biological Analyses of Inequalities
Research Abstract
Background
Prostate, breast, and pancreatic cancers all have a disproportionately higher rate of aggressive
tumor grade and early onset in Black patients, with recent spikes of high incidence in West African
nations compared to other African regions. The genetic background correlations implicate
predispositions. Members of our SAMBAI team of investigators have pioneered genomics in
cancer disparities research, and over the past two decades, we have uncovered compelling
evidence of distinct immunological mechanisms associated with genetic ancestry. Our SAMBAI
team members have developed methods to quantify environmental exposures and interrogate the
lived experiences of marginalized populations, including epigenetic responses to racism.
Aims
We will partner with scientists across the US, Africa, and the UK to build an unprecedented
resource, the SAMBAI Biobank and Data Repository for Cancer Equity Research. We will
generate a comprehensive, accurate, and relevant measurement of social, environmental,
genetic, and immunological factors to complete an integrated set of analyses to define the causal
vs. modifier relationships of disparate outcomes in diverse underserved populations. We will
establish a sustainable framework for team science approaches with under-represented partners
and establish best practices for coordinating cancer equity research on a global scale.
Methods
We propose to utilize multiple methods across our different work packages. Social Determinants
include self-reporting surveys and database abstractions. Exposomes utilize mass spectrometry
of plasma. Genomics will utilize three sequencing methods on germline and tumor tissue,
including long read, short/deep, and ultra-low pass whole genome sequencing. Lastly,
immunological profiles will be measured with spatial transcriptomics and circulating multiplex
immunoassays. These data require novel computational frameworks, including cloud-based
virtualization and the use of machine learning technologies to identify novel associations across
the strata of social to spatial data elements and across our diverse geographic and ancestral
SAMBAI cohorts.
Utility and Impact
We will improve research capacity in under-resourced environments for large-scale cancer
research and equitable access to data with equitable feasibility to improve treatment and
outcomes. We will define interactions of environmental exposures, social determinants, and
genetic ancestry that determine immunological landscapes of primary tumors and/or circulating
immunological profiles in patients of African descent. Our project will contribute a data repository
with 100K features/patient, for 40,000 patients. The impact on this population includes a novel
trial design, in collaboration with our patient advocacy partners, to ensure that the specific
genomic and immunological features we uncover become part of targeted precision oncology
theragnostic options.